Center for Research/Nutrition & Health among the Elderly

(Revised Abstract) DESCRIPTION: Puerto Rican older adults living in the U.S. mainland have been identified as a group highly at risk of excess chronic conditions, particularly diabetes, depression, and physical impairment. Few studies have been conducted on this rapidly growing and generally low-income ethnic group. To reduce health disparities, it is necessary to understand the factors that combine to progress to poor health outcomes. The overall aim of this Center is to perform a series of inter-related studies involving a cohort of older adults of Puerto Rican origin to evaluate specific stressors affecting the Puerto Rican community, and to determine the effect of these stressors on allostatic load and, in turn, on disease-specific outcomes. The Center will include four research projects. Project 1 is a prospective 2-year cohort study that will investigate both baseline and 2-year prospective associations between psychosocial stressors and allostatic load; and in turn, allostatic load and functional decline, specifically depression, cognitive decline and physical disability; along with the role of support, and vitamin intake and status in modifying these associations. Project 2 is a sociological investigation of psychosocial stressors and their measurement using both qualitative and quantitative methodology to gain contextual understanding of the sources of stress in this population that relate to allostatic load, and adapt instruments for its measurement. Project 3 consists of intervention studies. Using subsets of the baseline study, researchers will investigate the effectiveness of three different 2-year interventions in reducing indicators of allostatic load. Each is designed to be feasible for expansion by community agencies if effective. These include: 1) vitamin supplementation; 2) food coupons and nutrition education; and 3) social support and participation. Project 4 will investigate genetic contributions of allostatic load. Investigators will explore the relationship between selected gene variants and allostatic load at baseline and with change over time, and will investigate the interaction between gene variants and responses to the differing nutrition and social interventions. Three cores will work with all projects, including administrative, statistical, and laboratory cores. A pilot grants program during years 2 through 4 will encourage additional investigations relevant to the Center theme.